Project 1: Targeted therapeutics for pediatric low-grade glioma

Project Summary
Pediatric low-grade gliomas (pLGGs) are collectively the most common brain tumor of childhood and
associated with devastating and life-long morbidity. pLGGs most often arise from single genetic driver events
involving the BRAF oncoprotein. This finding has paved the way for precision medicine approaches for pLGG,
leveraging MEK, BRAF and pan-RAF inhibitors. Research within our prior SPORE program identified the RAF
inhibitor tovorafenib as a promising compound for BRAF-altered pLGGs and generated structural insights into
its function. Our Phase 0/1 Clinical Trial of tovorafenib led to breakthrough drug designation by the FDA and
set the stage for a company-sponsored Phase 2 trial (FIREFLY-1) of tovorafenib in recurrent pLGG. While
early results are encouraging, response to tovorafenib is variable across patients for unclear reasons and there
remain important unmet needs for children with pLGG. There is a need to better understand RAF alterations
within pLGG at the cellular level and investigate if more specific RAF inhibitors, or combination therapies, could
improve the therapeutic window and efficacy. Additionally, many children with pLGGs will be cured by standard
of care (i.e. surgery and chemotherapy), and it is difficult to predict who needs targeted therapies and who can
be spared additional, potentially toxic treatments. Even children who are ultimately cured by standard of care
are followed with periodic MRIs that can be stressful for patients and parents alike. Non-invasive prognostic
technologies are needed to better define risk of recurrence in pLGG. To address these needs, we have three
specific aims: (1) to define RAF and MEK inhibitors with enhanced efficacy and tolerability for targeted
inhibition for pLGG, (2) to conduct a genomic “audit” of WT RAF expression in pLGG, and (3) to develop non-
invasive “child friendly” predictors of which children with pLGG are most likely to require and respond to RAF
antagonists. For (1), we will determine if (and how) other RAF isoforms aside from BRAF play a role in pLGG
tumor development and assess which RAF and MEK inhibitors, alone or in combination, most selectively target
the relevant RAF isoforms. For (2), we will leverage novel single-cell genomic profiling and mass spectrometry
technologies to probe the expression and activation state of RAF isoforms (A, B, and C) in surgically resected
pLGGs. The aim 2 study plan may explain why certain BRAF-altered tumors do not respond as well to
tovorafenib. For (3), we will utilize emerging, imaging-based artificial intelligence (AI) techniques to analyze
longitudinal MRI scans from a large multi-institutional database and the FIREFLY-1 tovorafenib study. We will
determine how volumetric trajectories change over time in pLGG patients on and off therapy, and if trajectories
can predict clinical progression. We will determine if voxel-based deep learning analysis of longitudinal MRI
can better predict recurrence and select patients who do (or do not) need RAF antagonists. Together, these
investigations will advance our understanding of pLGG at the micro- and macroscopic scale and provide
insights and tools to improve the therapeutic window of targeted therapies for children with pLGG.

Public health relevance
Project Narrative Pediatric low-grade gliomas are the most common brain tumors of childhood and can cause devastating and life-long quality of life problems. In this study, we will combine advanced cancer cell analysis techniques and medical imaging-based artificial intelligence to improve targeted therapies, tumor monitoring, and prediction of recurrence in children with low-grade gliomas. The research will result in knowledge and tools that help us design better and safer therapies and determine how (and when) to best use those therapies in children with low-grade gliomas.